Cancer Center Administration

ADMINISTRATION
PROJECT SUMMARY/ABSTRACT
The UC Davis Comprehensive Cancer Center's (UCDCCC) Administration team provides the foundation
necessary to foster, support, and promote the UCDCCC's basic, clinical, translational, and population-based
research in order to mitigate the cancer burden in the catchment area and beyond. Administration supports the
Director; Senior Leaders; Program Leaders; Shared Resource Directors; Office of Community Outreach and
Engagement; Office of Education, Training, and Career Development; and the Office of Clinical Research. Its
procedural functions are to provide fiscal management and administrative support for the NCI Cancer Center
Support Grant (CCSG) and all related activities to include membership, information technology, space
management and allocation of resources, development, strategic communications, fostering collaborations
across the university to meet the scientific goals of the Center; and ensuring effective and efficient operation of
the Center's organizational units. The Specific Aims for Administration are to: 1) Advance the Center's mission,
vision, and values through administrative leadership in the strategic planning, management, and organization
of the Cancer Center; 2) Foster inter-and intra-programmatic collaborations and communication to leverage the
expertise of the Center's membership to facilitate research addressing the cancer burden of the UCDCCC
catchment area; and 3) Provide financial management and administrative oversight to ensure the efficient and
optimal use of UCDCCC funds and resources in order to promote scientific productivity and impact.